Defining the mechanisms that drive novel cyclic nucleotide signaling in immune defense

Project Summary- R35 Application PI: Benjamin R. Morehouse Ph.D.
The innate immune system is the critical first line of defense against microbial pathogens and is also a
key player in the response to cellular stress. A thorough understanding of innate immune function and
disfunction is necessary if we are to meet the healthcare challenges that face modern human society.
Innate immunity is common to all life on this planet, however how exactly diverse organisms, especially
those considered to be ‘non-model’, defend themselves from infection is an underdeveloped field of
research that may yield clues to understanding of our evolutionary history and provide new insights into
the organization and functioning of human immunity. Surprisingly, we find that parts of the human innate
immune system have ancient origins that can be traced as far back as the antiviral defense pathways
of bacteria and archaea. Among these evolutionary connections we find many mechanistic similarities
but also significant differences in form and function. Our particular interest lies in the shared strategies
of cyclic nucleotide second messenger signaling pathways of immunity, the use of specialized chemical
compounds that mediate antiviral immune defense. The antiviral and antitumoral cGAS-STING (cyclic
GMP-AMP synthase-stimulator of interferon genes) cyclic dinucleotide signaling pathway in humans is
analogous to cyclic oligonucleotide-based antiphage signaling systems (CBASS) in prokaryotes and
we have uncovered many striking elements of conservation between these defensive mechanisms.
Pycsar (pyrimidine cyclase system for antiphage resistance), is a similar prokaryotic immune defense
pathway that operates through production of cyclic pyrimidine mononucleotides. Through detailed
exploration and characterization of CBASS and Pycsar immunity that generate cyclic nucleotide
signals, we will delineate the modes of viral activation, probe the mechanisms of nucleotide selectivity
for both cyclase enzymes and cyclic nucleotide receptors, and define the functional consequences of
effector activity on cell growth and viral infection outcomes. Using a combination of bioinformatic
analysis, biochemical testing, and structural biology approaches, we will confirm activities and
phylogenetic links between diverse bacterial, fungal, and mammalian homologs to establish the
relationships shared between cyclic nucleotide signaling pathways. We will examine the connections
between evolutionarily distant immune systems, potentially leading to identification of new strategies
for pharmacological targeting and destruction of antimicrobial resistant pathogens, and we stand to
uncover more of the mechanisms that shape our own immune system which will benefit humankind in
the fight against infectious agents, cancer, and autoimmune disease.

Public health relevance
Project Narrative- R35 Application PI: Benjamin R. Morehouse Ph.D. The innate immune system is the critical first line of defense against pathogens. Surprisingly, parts of the human innate immune system have ancient origins in the antiviral defense pathways of bacteria and archaea many of which rely on distinct chemical compounds used for signal transduction. Through examination of the connections between evolutionarily distant immune systems, we will identify new strategies for pharmacological targeting and destruction of antimicrobial resistant pathogens, and we stand to uncover more of the mechanisms that shape our own immune system which will benefit humankind in the fight against infectious agents, cancer, and autoimmune disease.